Interactions between RV-C and its receptor CDHR3 in the development of chronic rhinosinusitis

PROJECT ABSTRACT
Rhinovirus (RV) infections are ubiquitous across age, gender, and ethnicity and are the most frequent reason
for healthcare visits. In the majority of affected persons, the symptoms of RV infections are mild and self-limiting.
In persons with chronic rhinosinusitis (CRS), however, RV infections are a major cause of CRS exacerbations
and associated morbidity. Recently, we found that RV-C species are common in adults, and that RV-C infections
result in greater sinonasal symptoms compared with the well-studied RV-A and RV-B species. We also
determined that rs6967330, a genetic risk variant in the recently discovered RV-C Cadherin Related Family
Member 3 (CDHR3) viral receptor, causes a two-fold increase in the odds for adult CRS. Although CRS is a
heterogeneous disorder, transcriptome studies of surgical tissues have determined significant dysregulation of
genes associated with chemokine/cytokine signaling and epithelial-mesenchymal transitions (EMT). The
objective of this application is to (i) determine if subjects with CRS and the rs6967330 CDHR3 risk allele
have a different molecular endotype in response to RV-C infections as compared with those with the
more frequent wild-type allele and (ii) determine if adult CRS subjects with the rs6967330 allele are more
likely to have CRS exacerbations with RV-C infections compared to RV-A and RV-B infections. We
hypothesize that in vitro studies of air-liquid-interface (ALI) cultures with the rs6967330 CDHR3 risk allele will
generate a molecular endotype characterized by (i) increased RV-C binding and replication, ii) increased
cytokines/chemokines associated with types 1 and 2 immunity, and iii) differentially expressed genes (DEGs)
and EMT pathways associated with airway remodeling compared to epithelia expressing the wild-type allele.
Likewise, we hypothesize that our in vivo studies of CRS subjects with the rs6967330 allele will reveal an
increased number of CRS exacerbations secondary to RV-C infections that are characterized by increased
sinonasal symptoms, nasal cytokine production, and transcriptomic changes in airway remodeling after infection.
There is a critical need to understand the molecular mechanisms that underlie the increased pathogenicity of
RV-C infections in persons with the rs6967330 CDHR3 risk allele to inform the development of new targeted
strategies to prevent and slow the progression of CRS.

Public health relevance
PROJECT NARRATIVE The current proposal provides a unique opportunity to investigate the role of rhinovirus infections and genetic risk factors in chronic rhinosinusitis (CRS) using in vitro cultures and in vivo human studies. We will identify molecular mechanisms in the pathophysiology of CRS, with a specific focus on determining if RV-C infections in individuals with the rs6967330 CDHR3 risk allele predispose persons to CRS exacerbations. The proposed research is relevant to public health, as the development of targeted strategies have the potential to reduce the incidence and severity of viral upper respiratory infections and CRS exacerbations.